Training in Infectious Disease Epidemiology (TIDE)

ABSTRACT
As dramatically illustrated by the CoVID-19 pandemic, endemic and epidemic infectious
diseases pose increasing global danger as the world becomes more interconnected. However,
there are relatively few institutions engaged in training infectious disease (ID) epidemiologists.
Of those that are trained, relatively few are equipped to work at the crossroads of lab science
and population-based clinical and behavioral research.
The UNC Epidemiology Department is applying for a 4th 5-year funding cycle for our Training in
ID Epidemiology (TIDE) NIAID T32. Our TIDE program occupies a unique niche in the T32
portfolio at NIAID as one of only seven training grants with an ID epidemiology focus (out of 177
active NIAID T32s). Our program has been very successful in several ways. First, with impetus
from the T32, we developed a core curriculum in ID epidemiology and made sure that all of our
trainees were exposed to interdisciplinary approaches to ID research. We have had three PhD
trainee slots per year for all 15 years, and one post-doc slot per year for the past 10 years.
Second, our trainees have been highly successful in obtaining jobs in ID epidemiology. Of the
30 trainees who have finished their training programs, 14 have academic appointments (6
tenure-track, 6 research or clinical track, 2 postdoc) and 10 are at the CDC, either in the EIS or
as full-time employees. The others (n==6) all have research-focused positions in other public
health organizations or agencies. Third, our efforts at increasing diversity over the past two
cycles have paid off: 6 of the 24 trainees in our last two funding cycles (25%) have been under-
represented minorities. We also have excellent representation of female trainees (77% to date).
For the next 5-year cycle, we are planning to continue to emphasize interdisciplinary research in
our three thematic research areas of ID microbiology, social influences on ID epidemiology, and
ID clinical research. Our pre-docs will all incorporate interdisciplinary work into their research.
Our post-docs will be required to do interdisciplinary research with co-mentors – one
epidemiologist plus one “interdisciplinary” co-mentor, with expertise in laboratory, behavioral or
clinical research aspects of infectious diseases. In addition, we plan to further strengthen our
professional development training and our outreach efforts to minority candidates.
In summary, we hope to build on the remarkable success to date of this training program by
continuing to train outstanding young infectious disease epidemiologists to meet an important
public health need.

Public health relevance
PROJECT NARRATIVE The need for rigorously trained infectious diseases epidemiologists has never been more evident than during the CoVID-19 pandemic of the past two years. The Training in Infectious Diseases Epidemiology (TIDE) T32 training program fills a unique and critical training niche in preparing academic and clinical researchers in interdisciplinary infectious diseases epidemiology. Funded for 15 years, we seeks to continue for another 5 years our work to train first-class academic and clinical infectious diseases epidemiology researchers to combat the infectious diseases of today and prepare for those of tomorrow.